Maternal Autoantibody Reactivity, Gestational Inflammation, and Child Neurodevelopment (MARGIN)

ABSTRACT
Approximately one in six children in the US is affected by neurodevelopmental disorders (NDD). A wide range
of medical and psychiatric conditions commonly co-occur with NDD, impacting quality of life. The causes of
NDD are largely unknown, and few modifiable risk factors have been identified. A growing body of evidence
supports a critical role for both genetic and environmental factors, particularly during gestation and the early
postnatal period. Understanding the underlying etiology is crucial, as the identification of risk factors and the
mechanisms by which they act would allow for earlier identification, treatment, and prevention of NDD and
associated morbidity. In our currently funded IMPaCT study (1R01HD095128), we are testing the hypothesis
that maternal inflammation during pregnancy stemming from immune or metabolic dysregulation adversely
impacts neurodevelopment. We are leveraging the unique resources of the Kaiser Permanente Research
Biobank Pregnancy Cohort to conduct a longitudinal prospective investigation of maternal gestational
inflammatory conditions, immune and metabolic biomarkers during pregnancy, and maternal genetics in
relation to NDD. The goal of this new application is to extend the aims of IMPaCT to interrogate additional
gestational biomarkers - maternal autoantibodies (MA) to fetal brain proteins - in the pregnancy blood samples
collected from the mothers of 750 ASD, 2000 developmental delay (DD), and 2000 general population (GP)
control children. Our overarching hypothesis is that maternal gestational immune/metabolic
dysregulation is associated with the presence of MA during pregnancy which predisposes to altered
neurodevelopment of the child. In Aim 1, we will examine maternal risk profiles related to the presence of
MA during pregnancy that are associated with NDD. In Aim 2, we will explore whether maternal genetics are
associated with the presence of MA during pregnancy. In Aim 3, we will examine the joint effects of maternal
MA reactivity and maternal clinical characteristics, biomarkers of immune and metabolic function and genetic
factors on ASD and DD, on phenotypic subgroups of ASD (ASD+/-Intellectual Disability (ID), ASD+/-
developmental regression) and DD (language delay, motor delay, global delay, ID), and on clinical subtypes of
the child defined by commonly co-occurring inflammation-mediated immune and metabolic conditions,
and determine if associations differ by child sex. We seek funds to assay for MA in the maternal pregnancy
biospecimens from the ~2500 mothers in our IMPaCT cohort plus an additional ~2250 mothers and perform
statistical analyses to address our specific aims. This large scale, comprehensive study provides a framework
to explore relationships between maternal immune dysregulation and metabolic function, maternal
autoantibody reactivity in the first and second trimesters, maternal genetics, and risk for a range of
neurodevelopmental disorders in children. Findings will contribute to the development of prenatal and newborn
screening for adverse neurodevelopment, ultimately enabling earlier intervention and primary prevention.

Public health relevance
NARRATIVE STATEMENT Neurodevelopmental disorders have become increasingly common, yet their causes remain largely unknown. The proposed research has the potential to identify immune and metabolic profiles during pregnancy that indicate risk for specific NDD. This would support the development of prenatal screening for NDD, leading to earlier intervention and the possibility of preventing future morbidity and improving quality of life.